Investigating the Recruitment of Lateral Hypothalamic Circuits for Encoding Fear Memories Following Experience with Reward Learning

PROJECT SUMMARY
Decades of elegant research has led to development of rich models of how we encode fear memories. The fear
circuit that has emerged from this research is complex. However, at the center of nearly all models of fear
learning is the basolateral amygdala. Activity in basolateral amygdala neurons tracks fear learning, and
glutamatergic signaling in this region is necessary for the acquisition and expression of conditioned fear. Indeed,
it has been demonstrated that the “fear engram” in basolateral amygdala can be targeted and erased to reduce
fear. This has led to efforts to develop treatments to erase problematic memories in a manner that may eventually
translate to humans experiencing pathological fear as a result of maladaptive fear memories.
However, we have recently shown that a neuronal population usually restricted to learning about rewards, can
be recruited to encode fear memories as well (Sharpe et al., 2021, Nature Neuroscience). Specifically,
GABAergic neurons in the lateral hypothalamus are not necessary to encode fear memories in experimentally-
naïve rats. Yet if rats have had recent experience with reward learning, which is dependent on hypothalamic
function, these neurons become critical to encode the fear memory. Importantly, this is in the context of an
experimental design that controls for many experimental variables associated with experiencing fear and reward
learning experiences. This suggests that reward learning primes the hypothalamus to encode fear memories.
We will examine the impact that recruitment of the lateral hypothalamus has for the well-documented role of the
basolateral amygdala in encoding fear memories. Our preliminary data suggest that reward learning shifts
the fear circuit away from the basolateral amygdala and towards the lateral hypothalamus. We further
hypothesize that there is a temporal gradient to the involvement of the lateral hypothalamus in fear, such
that this role will decay with time from the reward learning experience. To formally test this, we will use
cell-type specific optogenetics and fiber photometry of a genetically-encoded calcium sensor to manipulate and
record basolateral amygdala pyramidal neurons and lateral hypothalamic GABAergic neurons. We will do this
during fear learning in rats with or without reward learning experience, while varying the delay between reward
and fear learning procedures. This will begin to characterize a novel fear circuit comprising lateral hypothalamus,
expanding models of fear learning, and giving insight into how rewarding experience influences fear encoding.
This work is important to human mental health. We know that enhancements in basolateral amygdala activity is
produced by traumatic events, and correlated with subsequent enhancements in fear learning. Further, increased
amygdala activity to fear cues is seen in humans with post-traumatic stress disorder (PTSD). Thus, a shift away
from amygdala towards hypothalamic circuits to encode fear could confer resilience against problematic fear
memories. This work will expand our understanding of where fear memories are acquired and stored, and will
also reveal recruitment of a novel neural circuit that could confer resilience against problematic fear memories.

Public health relevance
PROJECT NARRATIVE The amygdala is often considered central to encoding of fear memories, spurring attempts to develop treatments that will allow us to target and erase problematic fear memories in this region. However, we have recently shown that lateral hypothalamus can also be recruited to encode fear, and our preliminary data suggest this constitutes a shift away amygdala encoding of fear. We will investigate the regional and temporal dynamics of this shift, expanding our models of fear learning, and suggesting caution in drawing boundaries around neural regions that may be specialized for the encoding of fear.